Seq-Scope: Microscopic Examination of Spatial Single Cell Transcriptome in Cell and Tissue Senescence

SUMMARY
Standard immunostaining or RNA in situ hybridization can examine only one or a handful of target molecular
species at a time; therefore, the amount of information obtained from a single experimental session is limited.
To overcome this, emerging Spatial Transcriptomics (ST) techniques aim to examine all genes expressed from
the genome from a single histological slide. There are three major methodologies of experimentally
implementing ST: the sequential in situ hybridization method, in situ sequencing method and spatial barcoding
method. Among these, the spatial barcoding method is the most straightforward, comprehensive and so far the
only method scalable for large amount of samples. The spatial barcoding method reveals both the RNA
sequence and their spatial locations by capturing tissue RNA using a spatially-barcoded oligonucleotide array.
The current spatial barcoding method, however, are intrinsically limited by their low resolution and low RNA
capture efficiencies; correspondingly, all currently available technologies failed to reveal the microscopic
details of the spatial transcriptome. We recently developed a technology named Seq-Scope, which overcomes
all these limitations. Seq-Scope has an effective resolution of 0.5-1 μm, and reveals over 20 transcripts per
μm2 area (~50 transcripts/μm2 estimated at library saturation). Both resolution and transcriptome capture
output of Seq-Scope are the best among all available technologies described in the literature so far. With this
unprecedented performance, Seq-Scope visualized spatial transcriptome heterogeneity at multiple histological
scales, including tissue zonation according to the portal-central (liver), crypt-surface (colon) and inflammation-
fibrosis (injured liver) axes, cellular components including single cell types and subtypes, and subcellular
architectures of nucleus, cytoplasm and mitochondria. Seq-Scope also has a potential to improve and
complement current scRNA-seq approaches. In response to the SenNet announcement, we propose to adapt
and utilize Seq-Scope to provide atlases of cellular senescence in multiple tissues during normal human aging,
focusing on the following three aims: (1) Identify and Characterize Hepatic Senescent Cell Population during
Liver Disease. (2) Characterize Age-Associated Changes of Hepatic Spatial Transcriptome. (3) Combine Seq-
Scope with Detection of Senescence Protein and Cell-type Marker Proteins.
For all aims, we will begin with analyzing mouse tissue to establish the feasibility of monitoring cell and tissue
senescence (UG3), and then expand the work in human tissues using the tissue obtained from diverse
resources including the SenNet tissue mapping center (TMC) (UH3). Seq-Scope is a versatile technology,
which is quick, straightforward, scalable and adaptable. Once optimized, a single researcher can process 5-10
frozen tissue blocks every week to generate a high-quality spatial single cell transcriptome data. Therefore, our
team is confident that we will be able to adapt our technology to any of the tissue systems that are provided by
the SenNet TMC in the UH3 phase.

Public health relevance
PROJECT NARRATIVE We recently developed Seq-Scope, a spatial transcriptomics solution which can provide unprecedented resolution and outstanding data output. In the enclosed proposal, we propose to adapt Seq-Scope for detection and characterization of senescent cells from normal human tissue.